Precision Control of Universal CAR Activity by Small Molecule Adaptors

SUMMARY
Chimeric antigen receptor (CAR) T cell therapy has revolutionized blood cancer treatment and shows potential
for solid tumors, autoimmune diseases, and viral infections. We have developed a highly programmable
universal CAR called SNAP-CAR, which can target any cell surface antigen by associating with a chemically
modified adaptor antibody. However, CAR T therapy faces challenges such as limited specificity, susceptibility
to immune inactivation, and complex manufacturing for multi-antigen targeting. To overcome these hurdles, we
propose to develop small molecule adaptors for covalent reprogramming of SNAP-CAR. Small molecule drugs
offer distinct advantages over antibodies, such as oral availability, cell permeability, chemical synthesis and
modification, and lower production cost. We are capitalizing on these advantages and the utilization of covalent
and caging chemistries in proposing the following specific aims: 1) Develop small molecule adaptors, and
combinations thereof, for targeting of universal CARs to multiple antigens including simultaneous targeting of
tumor cells and neighboring immunosuppressive cells. 2) Enhance universal CAR targeting specificity through
chemical switches that respond to unique intracellular enzyme characteristics in disease tissue, in particular solid
tumors. 3) Expand the antigen targeting breadth of SNAP CAR T cells to neoepitopes on tumor cell surfaces
generated through covalent modification and major histocompatibility complex (MHC) display of intracellular
oncogene products. The MPIs' expertise in chemical synthesis and immunology will synergistically contribute to
the success of this project. The long-term goal is to improve accessibility to treatment and patient outcomes by
enhancing both the specificity and breadth of targeting through conditional and combinatorial control of the CAR
therapy. The strategies developed will be applicable to other universal receptor technologies and open up new
therapeutic possibilities across different disease indications.

Public health relevance
PROJECT NARRATIVE This project aims to overcome limitations of adoptive cell therapies utilizing receptor-engineered cells, which have shown high efficacy in treating blood cancers, but have faced challenges in treating solid tumors and are exceptionally costly. To address these issues, we are employing a universal adaptor strategy using drug-like molecules to program engineered T cells with new and enhanced specificities to efficiently eliminate multiple cell populations across a spectrum of diseases, making this approach more effective and universally applicable.